Core C - Bioinformatics Core

ABSTRACT
(Core C)
Bioinformatics Core
Core C: The Bioinformatics Core, will provide bioinformatics analyses of Next-generation sequence (NGS) data
such as bulk RNA-seq, single cell RNA-seq, ChIP-seq, ATAC-seq, as well as proteomics and metabolomics
analyses. Core C will also integrate the newly generated experimental data with public available datasets, use
the state-of-the-art computational models to investigate the combined data and provide a platform for the
generation of new hypotheses of novel genes and pathways for promoting cardiomyocyte proliferation and
cardiac regeneration. Core C will help each project to design their NGS / proteomics / metabolomics experiments,
and discuss the analysis, interpret the experimental results and provide new data which will serve as a platform
for hypotheses and future experiments. These services are best centralized given their inherent difficulty, their
reliance on sophisticated analysis skills and expertise, and requirement of consistency and reproducibility. There
are two specific aims (SAs) for studies that will be pursued in Core C: SA 1: To organize and analyze
computational datasets from transcriptional and proteomic studies performed by the respective projects
and integrate them with existing publicly available datasets. SA 2: To develop new algorithms that will
facilitate the discovery of novel genes and factors that will impact cardiomyocyte proliferation and
remuscularization. These aims will make the bioinformatics analysis easy to reproduce, accessible and
interpretable to each project led team and produce high-quality and in-depth analysis for large-scale NGS,
proteomics and metabolomics data. Core C personnel are well-trained in all aspects of the services to be
provided, as we have collaborated on bioinformatics projects over the past ten year period at UMN and as
members of programmatic projects. All of the required equipment and resources are in place for the proposed
projects.

Public health relevance
NARRATIVE (Core C) Bioinformatics Core The mechanisms that govern cardiomyocyte proliferation and remuscularization following a heart attack are unknown. The overall goal for Core C: The Bioinformatics Core is to assist all the projects with their data analyses to promote discovery and facilitate their research aimed at the definition of future therapeutic factors that will facilitate cardiomyocyte proliferation and heart regeneration.